Cytoskeletal Function in C. elegans Embryos

Project Summary
For 30 years now, our laboratory has used live cell imaging with fluorescently marked proteins,
and classical and molecular genetic approaches with the early embryo of the nematode
Caenorhabditis elegans to investigate cytoskeletal function and regulation. In addition to having
isolated temperature-sensitive mutations in many essential genes that control cytoskeletal
function, bypassing earlier requirements, we have more recently incorporated extensive use of
CRISPR/Cas9 to rapidly generate fluorescent protein fusions to endogenous loci, and to
degron-tag genes required for cytoskeletal function such that we can bypass earlier
requirements with auxin treatment. The advent of CRISPR/Cas9 and degron-tagging, along with
gene replacement strategies that benefit from CRISPR/Cas9 technology, now enable still more
powerful investigation of gene function in vivo using this model system. Our research program
over the next five years will focus on oocyte meiotic cell division in C. elegans, which provides a
powerful platform for investigating acentrosomal spindle assembly and the regulation and
function of an animal cell cortex, with relevance to cancer, human fertility, and tissue
engineering. The power of C. elegans genetics, and its amenability to live cell imaging, together
with ongoing advances in high resolution light microscopy and our proposed novel and exciting
application of Atomic Force Microscopy, make C. elegans an exceptional model system for
investigation of these essential processes.

Public health relevance
Project Narrative Our research program over the next five years will employ powerful advances in molecular genetics, light microscopy and atomic force microscopy to investigate mechanisms that regulate the cytoskeleton during cell division in the model organism Caenorhabditis elegans. Our major goals are to (i) advance our understanding of cytoskeletal regulation in general, as lessons gained from C. elegans oocytes and early embryos are likely to prove relevant in a wide variety of animal cell contexts; (ii) more specifically to advance our understanding of acentrosomal spindle assembly, which is important for both meiosis and mitosis; (iii) explore the C. elegans oocyte cortex as a model for investigating the role of microtubules in an animal cell cortex; and (iv) collaboratively apply Atomic Force Microscopy to isolated C. elegans blastomeres and oocytes to investigate the biophysical properties of animal cell cortices.